Clinical Research Facilitation Core

Specific Aims 1. To facilitate the implementation of patient oriented HIV/AIDS related research at UCLA 2. To assist investigators with the regulatory aspects of biomedical and behavioral patient-oriented research 3. To establish and maintain a clinical database that will interface with the CFAR/CNICS program. The primary responsibility of the Clinical Research Facilitation Core is to facilitate the process of IRB submissions for faculty, fellows, new researchers and translational researchers who do not have a great deal of experience with human subjects research. While funding to facilities and equipment are crucial to the conduct of research, regulatory delays in the conduct of research are often overlooked. This core in itself is innovative as it provides investigators with resources not previously available to reduce delays. By its very nature, this core will support new initiatives. It will encourage research among new faculty, young faculty and fellows. The core is fully linked into the CFAR seed grant process and allows recipients to become productive in their research far earlier than if they did not have the Core to assist them. The Core has created both a website and a blog to share the resources learned while submitting applications. Additionally, the Core provides seminars to investigators and staff to increase knowledge of regulatory pitfalls and procedures. In reducing regulatory delays in. the conduct of patient-oriented research, this Core helps to maintain UCLA investigators on the cutting edge of research in HIV. PERFORMANCE SITE(S) (organization, city, state) University of California, Los Angeles Center for Clinical AIDS Research and Education 9911 W. Pico Blvd. Suite 980 Los Angeles, CA 90035 PHS 398 (Rev. 04/06) 614